Influence of HFE on metal pharmacokinetics and neurotoxicity

ABSTRACT My research interests center around metal toxicology and physiology-based pharmacokinetic-pharmacodynamic (PBPK) modeling. My goals are to further investigate the relationship between pharmacokinetics of metal absorption and metal-induced toxicity in the context of environmental exposure and genetic susceptibility (gene-environment interactions). The major underlying hypothesis of this research proposal is that absorption of ingested and inhaled metals is up-regulated upon HFE-deficiency such that patients with mutations in HFE (C282Y; H62D) are more vulnerable to neurotoxicity induced by environmental metal exposure. Mentored phase: During the mentored phase of this grant at the Harvard School of Public Health, I will gain knowledge and expertise in new areas of research that complement my past training and that are essential for my future studies as an independent investigator. The research areas are: i) biochemical assays for expression of DMT1 and its regulation by iron status and ii) pharmacokinetics of metal absorption from various routes of exposure, and inhalation in particular. The specific aims are: 1) To determine protein levels of DMT1 in duodenal, respiratory and olfactory epithelium from 3, 6, and 10 wk-old Hfe-/- and Hfe+/+ mice fed iron-deficient, basal and iron-loaded diets. 2) To determine and compare the pharmacokinetics and tissue distribution of 59Fe and 54Mn administered to Hfe-/- and Hfe+/+ wild-type control mice by intravenous injection and by intragastric gavage. 3) To determine and compare the pharmacokinetics and tissue distribution of 54Mn administered to Hfe-/- and Hfe+/+ mice by intranasal and intratracheal instillation. Independent phase: My long-term career goal is to obtain a tenure-track faculty position at an academic institution where I will be able to expand my area of research, train and instruct graduate and undergraduate students, and collaborate with and learn from my academic peers. Utilizing the training and results obtained during the mentored phase, the hypothesis that HFE-deficiency enhances manganese neurotoxicity will be tested. 4) To test motor coordination and learning/memory capacity of Hfe-/- and Hfe+/+ mice after Mn exposure. 5) To examine CNS damage in Hfe-/- and Hfe+/+ mice due to Mn intoxication. 6) To develop a physiology-based pharmacokinetic/pharmacodynamic model to describe the role of Hfe on metal pharmacokinetics and toxicity. By directly examining the influence of HFE on the uptake and disposition of metals and their associated neurotoxicity, this investigation will provide the groundwork to assess the future risk of health effects due to metal absorption from environmental sources and genetic vulnerability. The research has broad relevance to the management of HFE-associated hemochromatosis and iron-overload.

Public health relevance
PROJECT NARRATIVE This investigation will provide the groundwork to assess the future risk of health effects due to metal absorption from environmental sources and genetic vulnerability. The research has broad relevance to the management of HFE-associated hemochromatosis and iron-overload. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS MENTORED PHASE The major underlying hypothesis of this proposal of the Mentored Phase is that DMT1 functions as the major transporter of toxic divalent metals in the respiratory and gastrointestinal tracts and that absorption of these metals is up-regulated in individuals with HFE-associated hemochromatosis. If correct, this model would suggest that individuals with mutations in HFE have greater genetic susceptibility to environmental metal exposure near contaminated waste sites. The Mentored Phase of the award period will provide the training and baseline measurements necessary to test the hypothesis during the Independent Phase. The specific aims are: 1) To determine protein levels of DMT1 in duodenal, respiratory and olfactory epithelium from 3, 6, and 10 wk-old Hfe-/- and Hfe+/+ "wild-type" control mice fed iron-deficient, basal and iron-loaded diets. The DMT1 expression will be measured by Western blot and immunohistochemistry to determine the modifying effects by gene (Hfe), age, and iron status. Blood will be collected to analyze hematological parameters. 2) To determine and compare the pharmacokinetics and tissue distribution of 59Fe and 54Mn administered to Hfe-/- and Hfe+/+ mice by intravenous injection and by intragastric gavage. 3) To determine and compare the pharmacokinetics and tissue distribution of 54Mn administered to Hfe- /- and Hfe+/+ mice by intranasal and intratracheal instillation. Bioavailabilities (gastrointestinal, pulmonary, and olfactory routes) and tissue partition coefficients of metals will be determined and correlated with obtained biochemical findings (Aim #1). INDEPENDENT PHASE The major underlying hypothesis of this proposal of the independent phase is that absorption of inhaled Mn is up-regulated upon HFE-deficiency such that patients with mutations in HFE (C282Y; H62D) are more vulnerable to neurotoxicity induced by environmental metal exposure. The proposed research will contribute fundamental understanding of physiological risks associated with gene effects on metal-induced toxicity and, more specifically, the interactions between HFE and manganese neurotoxicity. The Independent Phase of the award period will provide the comprehensive understanding of metal toxicity controlled by HFE-iron metabolism that had been characterized in the Mentored Phase. The specific aims are: 4) To test motor coordination and learning/memory capacity of Hfe-/- and Hfe+/+ mice after Mn exposure. Mice will be tested for motor coordination (rotarod) and learning/memory capacity (Morris water maze). The results will be correlated with data obtained in Aims #1 and 3. 5) To examine CNS damage in Hfe-/- and Hfe+/+ mice due to Mn intoxication. To verify that motor and behavior problems identified in Aim #4 are due to Mn-induced CNS damage, indices of oxidative stress (3-nitrotyrosine and 8-hydroxy-2'deoxyguanosine levels) and dopamine will be determined. 6) To develop a physiology-based pharmacokinetic/pharmacodynamic model to describe the role of Hfe on metal pharmacokinetics and toxicity. I will establish a physiology-based pharmacokinetic/pharmacodynamic (PBPK/PD) model to integrate hematological and biochemical parameters of DMT1 (Aim #1), pharmacokinetic parameters (Aim #2 and 3), behavioral pharmacodynamic responses (Aim #4) along with biomarkers for CNS damage (Aim #5) and to characterize the role of HFE in metal absorption and neurotoxicity.